CORALE-SeroNet Admin Core

ABSTRACT for Administrative Core
The Administrative Core will provide a centralized, coordinated infrastructure for effectively supporting,
evaluating, and stimulating progress towards the overall scientific goals of the CORALE-SeroNet U54 Program.
The Core led by the Program Directors (Drs. Susan Cheng, Jane Figueiredo, and Michael Karin) will interact
with Internal and External Advisory Committees and a Community Advisory Board and will provide regular
feedback on programmatic initiatives and progress toward achieving the following goals. First, to provide
leadership to ensure overall program productivity and effective collaboration across the SeroNET consortium.
The Administrative Core will provide: (a) centralized and efficient administrative support and coordination of all
CORALE-U54 activities and all collaborative efforts across the SeroNet consortium; (b) regular monitoring and
evaluation of all project activities and generation of reports for internal and external stakeholders including
assessments of opportunities for translation between basic and clinical research and the most effective allocation
of resources; (c) engagement with advisory committees and external organizations, including other SeroNet
centers and external investigators regarding progress toward the overall goals of SeroNet and opportunities for
augmenting or integrating scientific and training activities; (d) financial administrative support to ensure
appropriate management of budgets and financial resources; (e) support to ensure research compliance and
integrity of all research programs; and, (f) administrative coordination for the dissemination of data and results,
including data sharing and publication of all research findings. In particular, the Leadership Administrative Core
has an active communication plan and resources for disseminating our ongoing findings to the broader clinical,
research and lay communities. Second, the Administrative core will provide organizational structure and
management support for the Resource Cores. The Administrative Core will provide an efficient and centralized
administrative structure to support all activities of the two Cores: (a) Recruitment and Biobanking Core (RBC),
and (b) the Immune Bioanalytics Core (IBC). Thirdly. The Administrative Core will provide organizational
structure and management to collaborate within SeroNet and beyond. Our vision is to develop and manage a
research program that will integrate our team of population, clinical, translational, and basic science scientists
and unique patients resources with the broader scientific community led by SeroNET to meet the urgent need to
understand the underlying mechanisms and potential therapeutic approaches to address key knowledge gaps
regarding SARS-CoV-2 susceptibility and potential for immunity.